PASSA-Policy & Systems Science Analysis

PROJECT SUMMARY/ABSTRACT ? Policy and Systems Science Analysis Core The primary goal of the Policy and Systems Science Analysis Core (PASSA) of the Washington University Center for Diabetes Translation Research (WU-CDTR) is to support research focusing on policy assessment, implementation, systems analysis, and change leading to a reduced burden of diabetes and the promotion of health equity. This is accomplished through support of leading-edge analytical and modeling methods to reduce disparities and improve diabetes prevention and management. There is also an emphasis on building new partnerships and collaborations among policy and systems experts, diabetes scientists, and community stakeholders. PASSA provides a cohesive structure to deliver services that use policy and systems science analysis enabling WU-CDTR investigators to enhance the quality and efficiency of their work. PASSA addresses the large gap between the ability of researchers to link policy and systems interventions to the outcomes and prevention of diabetes. This gap suggests the need for services to assist in conducting policy and systems research targeting prevention and self-management of diabetes. By focusing on policy and systems methods, PASSA will further support diabetes-relevant research across the T2-T4 spectrum and promote translational research that is more likely to have long lasting environmental impact and produce systems changes that lead to positive clinical, economic, policy, and health outcomes. The aims of PASSA are to: (1) improve and expand the use of innovative and state-of-the-art policy research methods among WU-CDTR investigators; (2) enhance the use of novel systems science methods among WU-CDTR investigators; and (3) increase the capacity for policy and systems science methods in diabetes translation research among WU-CDTR investigators. PASSA has been used to support WU-CDTR investigators conducting diabetes policy and systems research, analysis, and evaluation. This novel Core has evolved based on input from investigators to better provide new services to meet a growing demand in the frontier area of systems science research. PASSA now provides an efficient interface between investigators and comprehensive policy- and systems-analytic research services that improve the quality of translational research in diabetes and is aligned with WU-CDTR themes of health equity, dissemination & implementation, and team science.